Microscale System for Functional T Cell Transcriptomics

Project Summary / Abstract
Single cell analysis technologies have transformed understanding of cellular physiology and disease,
allowing deep insights into the diversity of cell composition and genomic programming. Concurrently,
microscopy-based assays provide individualized measures of high-level cellular function, such as migration,
secretion of chemical factors, and interaction with neighboring cells. The ability to associate these complex
functions with specific -omic profiles would unite these two perspectives into a compelling framework for
understanding cellular physiology, but to date has not been successfully implemented. To this end, the
proposed study will combine microscopy-based analysis of cell function on micropatterned surfaces with an
emerging platform for single cell RNA sequencing (scRNA-Seq). These two platforms have individually led to
new avenues of investigation, and together will allow association of an individual cell’s function with its
transcriptome. This new system will be pursued in the context of T cells, key modulators of adaptive immunity,
and is inspired by the variation in cell migration our team has observed in cells isolated from patients
undergoing treatment for chronic lymphocytic leukemia (CLL). This short-term, exploratory / developmental
project will develop a first generation platform capable of processing numbers of cells that allow contemporary
transcriptomic analysis, a capability not currently provided by other systems. With the proposed platform, we
will carry out the first studies of how variation in cell migration is linked to differences in gene expression,
leading to identification of specific transcriptomic signatures associated with cell behavior. Building on these
initial discoveries, the proposal platform is well positioned to carry out analysis on complex cellular systems
such as those obtained from individuals being treated for CLL or other disease. By providing new interpretation
of scRNA-Seq data in the context of cell function, we envision that this system will lead to new diagnostic and
prognostic tools to improve human health.

Public health relevance
Narrative Single cell analysis techniques have transformed both basic research into disease physiology and the direction of therapy development. The proposed study will develop a platform that allows association of a cell’s transcriptome profile to complex cell functions observed in vitro. Successful completion of this project could provide new insight into cellular diversity and how to control adaptive immunity.